Functions of gustatory afferent neuron types.

Project Summary
Single-cell RNA sequencing (scRNAseq) has made unprecedented strides in discovering previously
unrecognized diversity of neuronal cell types and their functions. Using scRNAseq, we showed that the mouse
geniculate ganglion contains 3 molecularly distinct types of gustatory neurons that innervate taste buds, T1,
T2, and T3, each with unique patterns of gene expression. In a concerted effort from two well-established
laboratories, we now propose a multi-PI project to test hypotheses regarding distinct functions for each of the
major types of neurons and their subtypes. Our ultimate goal is to produce an integrated molecular and
functional categorization of gustatory neurons similar to what has been so powerfully effective in the auditory,
visual, and somatosensory systems. We propose using a newly-optimized method for in vivo confocal Ca2+
imaging, neuron-selective fluorescent markers, and chemogenetic silencing to reveal the functions of T1 and
T3 geniculate ganglion neurons. Specifically, using GCaMP-based Ca2+ imaging, we will test the hypothesis
that within the cluster of T1 neurons there are subclasses that respond to distinct taste qualities whereas
neurons within the T3 cluster respond to multiple, convergent tastes. We will further test the hypothesis that
T1 and T3 neuronal subtypes contribute to separate central pathways serving a number of taste-dependent
functions downstream of initial detection in the taste periphery.
Completing the above aims will move the field of taste into a new era of molecular-functional integration. Our
findings will assist electrophysiology and circuit tracing studies in taste, will shed light on the controversy over
labeled lines versus combinatorial taste coding, and will bring new information on gustatory neural pathways
that are so important to nutrition and ingestive behavior.

Public health relevance
Project Narrative Our selection of foods we consume is governed in large part by taste pathways in the periphery (sweet, salty, sour, etc). However, there is a paucity of information about the molecular identities of afferent sensory neurons that process taste signals and transmit these signals to the brain. Understanding how basic tastes are encoded by sensory neurons whose molecular profiles are known is key for understanding diet selection and making rational choices of what we eat.